Psychosocial and Genetic Effects on Gene Expression and Asthma

Abstract
In the past 8 years, we have studied a cohort of youth from metropolitan Detroit to investigate the effects of
psychosocial stressors and resources on health, with a speciﬁc focus on asthma symptoms (Asthma in the Lives
Of Families Today, ALOFT study). Our preliminary results from bulk RNA-seq analysis in peripheral leukocytes
demonstrate that psychosocial factors are associated with transcriptional changes for a large number of genes,
many of them involved in immunological functions. Importantly, we and others have uncovered an important role
for blood cell type composition in inter-individual variation in response to psychosocial environments and their
effects on immunological health and asthma symptoms. Here, we propose 1) to disentangle the contribution of
psychosocial factors and asthmatic state on patterns of transcriptional dysregulation; 2) to investigate the effects
of psychosocial factors on transcriptional regulation in blood cell type subpopulations; and 3) to determine the
role of genetic variation in modulating these effects and their consequences for asthmatic children's health. To
this end, we will use a combination of bulk and single cell RNA-sequencing on immune cells collected from
children with asthma and their asymptomatic siblings. The complementary expertise of our team will uncover
speciﬁc genetic and psychosocial factors associated with increased risk for poor physical health and wellbeing.
These results will be important to design personalized medical and behavioral interventions to alleviate disease
severity in children with asthma.

Public health relevance
Project Narrative This project will investigate the relationship between psychosocial experiences and health in children affected by asthma and their asymptomatic siblings. The goal is to dissect the role of different cell types, disease status versus psychosocial environment, and genetic variation in transcriptional dysregulation observed in children with asthma living in risky family environments.